Novel Therapeutics for Timothy Syndrome and Related Cardiac Channelopathy

Project Summary:
Calcium channel dysfunction in excitable cells, such as cardiomyocytes, neurons and beta-cells, induces lethal
cardiac arrhythmias such as Timothy syndrome, a severe form of genetic long QT syndrome, and also psychiatric
disorders such as autism and schizophrenia as well as abnormal insulin secretion, respectively. In preliminary
experiments using pharmaceutical approach, we found that activation of Sigma 1 receptor using its agonists
could alleviate the cellular phenotypes in human induced pluripotent stem cell (iPSC) and mouse models of the
genetic disease. The goal of this study is to examine the molecular mechanism underlying the beneficial effect
of Sigma 1 receptor activation on the phenotypes in ion channel regulation, action potentials, mitochondrial
function and gene expression in the genetic diseases. We will use human iPSC and rodent models to accomplish
our goal. In addition, we will design and synthesize new small molecules to develop novel Sigma 1 receptor
agonists that are more suitable for each phenotype in the genetic disease, taking advantage of our expertise in
pharmaceutical science and medicinal chemistry. Therefore, our translational study will provide new opportunity
of drug development for genetic syndromic disorders including cardiac arrhythmia, autism and abnormal insulin
secretion.

Public health relevance
Project Narrative: This project will investigate the molecular mechanism underlying a genetic syndromic disorder called Timothy syndrome and also related diseases including cardiac arrhythmia, autism and abnormal glucose metabolism. Our team will take advantage of new technology to test drug candidates in cardiac muscle cells and neurons derived from human patients as well as small animal models. This translational approach will open new avenue to identify novel therapeutics for genetic diseases.